PDX Core

PROJECT SUMMARY / ABSTRACT
U4HELPP PDX CORE
A profound limitation to personalized approaches for therapeutic development in cancer is the lack of relevant
patient derived models in all cancer types, especially those from underrepresented minority groups with more
aggressive, recalcitrant and/or advanced clinical stages. The overall objectives of United for Health Equity in
Living PDX Program (U4HELPP) will be to increase diverse representation and study of racial/ethnic minority
populations through development and investigations on more racial/ethnically diverse patient-derived xenograft
models (PDX) to advance cancer health disparity research. The U4HELPP PDX Core will serve as a central point
for patient-derived viable tumor tissue harvest and expansion to fully support Research Projects 1 & 2 and Pilot
Project and Trans-network Activities Core. The U4HELPP PDX Core will also serve as a central database of
these specimens with clinical and molecular characteristics, including ancestry, of each cancer subtype, linked
to molecular genomics.